Activation of the RXR/PPARγ axis improves long-term outcomes after ischemic stroke in aged mice

Ischemic stroke is a leading cause of death and long-term disability in elderly veterans. It is well established that
post-stroke immune responses have a substantial impact on the progression of ischemic brain injury and brain
recovery, but there are no clinical treatments that successfully harness the restorative power of the immune
system while also tempering inflammation-induced secondary injuries. The reasons for this gap are multifactorial,
but include a preclinical overemphasis on young adult animals, which simply do not display the same
pathophysiological mechanisms underlying brain ischemia as the aged, including the dynamic inflammatory
dialogue between glia and neurons. We propose to fill the critical gap in elderly veteran care by focusing on aged
animals and repurposing an FDA-approved drug at low doses to correct hyperactive immune responses and tip
the balance in favor of sustained tissue healing and long-term recovery of neurological functions.
To commence this goal, we have conducted pilot studies on proteins that are highly enriched in microglia
and brain-infiltrating macrophages (Mi/MΦ)—including the retinoid X receptor (RXR). RXR binds to peroxisome
proliferator-activated receptor γ (PPARγ) to govern the transcription of genes critically involved in redox status,
inflammation resolution, trophic factor production, and metabolism. Thus, RXR/PPARγ activation lies at the apex
of a decision tree for arbitrating between polymorphic, often-opposing immune responses in Mi and MΦ. To
engage this important biological target, we have chosen a selective RXR agonist, bexarotene, an FDA-approved
antineoplastic agent lacking in pan-immunosuppressive effects and with excellent safety profiles. The scientific
premise underlying the engagement of the RXR/PPARγ axis as a superior biological target for stroke is its ability
to titrate immune balance toward anti-inflammatory/pro-repair phenotypes, while avoiding indiscriminate
suppression of immune function in the vulnerable elderly.
The premise of this proposal is also strengthened by our new preliminary discoveries: 1) Mi/MΦ-specific
conditional knockout (mKO) of RXR or PPARγ worsens long-term outcomes after permanent distal middle
cerebral artery occlusion (dMCAO) in mice. 2) RXR or PPARγ mKO mice exhibit impairments in post-stroke
efferocytosis (Mi/MΦ phagocytosis of dying neurons) and resolution of neuroinflammation. 3) PPARγ mKO alters
the Mi/MΦ transcriptome, with heightened proinflammatory responses and impaired phagocytosis according to
RNA sequencing data. 4) Excitingly, intraperitoneal administration of low-dose bexarotene (10-20 times lower
than in clinical trials) improves long-term outcomes after dMCAO in aged mice (20 months old). Accordingly, our
research group is now in an excellent position to test the following core hypothesis: Activation of RXR improves
long-term outcomes after ischemic stroke by promoting efferocytosis and inflammation-resolving, pro-
repair microglial/macrophage responses. If funded, we will tackle three aims in a timely and efficient manner:
Aim 1: Systematically test if bexarotene improves long-term histological and functional outcomes in aged
(20 months old) stroke mice of both sexes.
Aim 2: Test the subhypothesis that bexarotene promotes efferocytosis in Mi/MΦ and attenuates acute
ischemic brain injury via activation of RXR.
Aim 3: Test the subhypothesis that enhanced inflammation-resolving, pro-repair actions of Mi/MΦ contribute
to bexarotene-afforded, RXR-dependent long-term beneficial effects against stroke.
We will use aged subjects of both sexes and deploy state-of-the-art tools, such as cell-specific, conditional
RXR knockout, electrophysiological measurements, stereological counting, and a battery of established behavior
tests to gain novel mechanistic insights into the role of Mi/MΦ in stroke evolution. A rigorously confirmed
beneficial effect of bexarotene on aged mice would facilitate its clinical translation into a potential stroke therapy
for military men and women as well as elderly civilians.

Public health relevance
Stroke is a devastating disorder and a leading cause of death and long-term disability in elderly veterans, as currently no therapy is available to alleviate post-stroke neurological deficits. The proposed study will explore bexarotene as a promising therapy for ischemic stroke. We will investigate whether bexarotene protects against ischemic brain injury and improves long-term neurological outcomes after experimental stroke in aged mice of both sexes. The studies proposed will also use state-of-the art approaches, comprehensive and long-term assessment of neurological functions, and aged subjects to gain novel mechanistic insights into the role of bexarotene in microglia and macrophage responses after ischemic stroke. This information will be valuable for future development of new stroke therapy for military men and women as well as elderly civilians.